Research Core

PROJECT SUMMARY/ABSTRACT – RESEARCH CORE COMPONENT
Fundamental to effectively studying nutrition and women’s health is having access to equipment and expertise
needed for nutritional status and health assessment. This includes equipment for various measurements of
anthropometry (e.g., weight, body composition), biochemical measurements (e.g., blood chemistries), clinical
assessments (e.g., signs and symptoms of nutritional deficiencies), and dietary assessments (e.g., food record
analysis). In addition, many researchers studying nutrition use indirect calorimetry and stable isotope method-
ology, and those conducting dietary intervention studies require the use of a kitchen. Our long-term goal is to
support a critical mass of multidisciplinary scientists synergistically studying nutrition and women’s health at the
University of Idaho. A primary objective in this Phase 1 COBRE Research Core is to establish a new and
unique Nutrition Analytics Core Laboratory (NACL). The NACL will be comprised collectively of 1) a unique
main suite of laboratories serving as its ‘hub’ and 2) a network of satellite laboratories and associated ‘Faculty
Subject Matter Experts.’ The main NACL hub laboratory suite will be comprised of a Wet Chemistry Labora-
tory, a Computer Laboratory, a Body Composition Laboratory, a Resting Metabolic Rate Laboratory, and a
Metabolic Kitchen. The NACL’s hub and satellite laboratories will be easily accessible by all faculty and staff
looking to leverage their broad capacities for research related to nutrition and women’s health. We will accom-
plish our goal through three aims: 1) establish the NACL, a new and unique research facility to serve the scien-
tific needs of the research projects in this COBRE for Nutrition and Women’s Health, 2) operate the NACL us-
ing best practices that include a comprehensive business plan, and 3) open the NACL to all COBRE and non-
COBRE scientists. PD/PI McGuire will provide broad oversight to the NACL which will be directed by Dr. Janet
Williams. Day-to-day operations will be overseen by a dedicated Research Support Specialist. The COBRE in
Nutrition and Women’s Health, including the NACL, will build institutional critical mass and capacity in nutri-
tion and women’s health research with the goal of establishing an international reputation within this scientific
theme. The NACL is innovative in that it builds a comprehensive facility that will eventually address nearly all
aspects of data collection and analyses pertinent to nutrition research. It will span the needs of scientists con-
ducting basic biological experiments to those focused on social or behavioral aspects of nutrition and those
developing novel computational approaches to understand the impacts of nutrition on women’s health across
the lifespan. The NACL will be impactful because it will allow University of Idaho researchers and regional col-
laborators unparalleled ability to study the broad range of nutrients, physiological conditions (e.g., growth,
pregnancy, lactation, exercise, weight loss or gain, aging), and health outcomes that encompass our theme of
nutrition and women’s health.